Layer 4 circuits and sensory processing

Abstract
The neocortex generates a representation of the outside world by combining information from different
sensory modalities and integrating this with internally generated information, such as memories and
expectations. Furthermore, cortical processing and perception are contextually adjusted by the actions of
neuromodulators released in the neocortex during specific behavioral states such as arousal and attention.
In most sensory systems, sensory information enters the cortex through projections from the sensory
thalamus that primarily target layer 4 (L4). Thus, the thalamocortical response transformations occurring in
L4 start the cortical processing of sensory information that results in a sensory percept that is optimized for
the behavioral needs of the animal. However, we still have an incomplete understanding of the
transformations of sensory input that take place in L4 during behavior and the circuits mediating these
transformations. This information is critical for a mechanistic understanding of sensory processing, which is
necessary for interventions to treat diseases resulting from altered sensory perception. Cortical processing
is mediated by dynamic microcircuits composed of excitatory or principal neurons (PNs), which transmit
signals to other areas and a diverse array of inhibitory GABAergic interneurons (INs), which sculpt cortical
circuits and are critical for signal processing. However, due to their diversity and low representation,
recording IN activity during behavior and understanding their function has been challenging. This project
uses an innovative approach (Channelrhodopsin-assisted patching), that facilitates the efficient targeted in
vivo recording of specific cell types at any cortical depth, to advance our understanding of L4 circuits. The
studies are focused on the two main IN populations in L4 of somatosensory cortex, the fast-spiking
parvalbumin--expressing basket cells (PV INs) and the somatostatin-expressing INs (SST INs), which
together account for 80-90% of L4 INs. Experiments in slices have led to the hypothesis that the function of
L4 SST INs, which are major targets of cholinergic influence, is to regulate PV IN activity. L4 PV INs
produce feedforward inhibition (FFI) of thalamocortical inputs and thereby control the feature selectivity of
L4 PNs. This application will test the hypotheses that L4 SST INs regulate PV IN-mediated inhibition of PNs,
and that the disinhibition of PNs produced in L4 as a result of the cholinergic activation of SST cells
contributes to the mechanisms by which ACh enhances sensory detection. To investigate the disinhibition
hypothesis, in Aim 1 we will study the changes in activity of L4 PV INs and PNs during behavioral states in
which SST INs normally increase their activity and the effects of manipulating SST IN activity. In Aim 2, we
will use a sensory detection task that depends on cholinergic modulation to investigate the role of L4 SST
IN activity on touch responses, and the contribution of the muscarinic activation of SST INs to the
cholinergic enhancement of sensory signals and behavioral performance.

Public health relevance
Project Narrative The cerebral cortex processes the sensory signals it receives from the outside world and integrates this information with internally generated information, such as memories and expectations, to generate a percept and guide behavior. An understanding of the cellular mechanisms by which the cortex processes sensory information is necessary to treat the many diseases that result from altered sensory perception. This project will use a novel electrophysiological method to record the activity of neurons in awake behaving mice to study the neuronal circuits that process sensory information in layer 4 of the mouse somatosensory cortex, which is the entry point of somatosensory information to the neocortex.